Developing a Two-way SMS Platform to Prevent and Treat Wasting Among HIV-infected and HIV-exposed Uninfected Children

PROJECT SUMMARY/ABSTRACT
Twenty-five percent of children with HIV-infection have childhood wasting (low weight-for-height or low mid-upper
arm circumference, and HIV-exposed uninfected (HEU) children are twice as likely to be underweight as
comparable HIV-unexposed children. Wasting is known to promote morbidity, HIV-progression, and mortality
among these children. Improving wasting prevention and treatment for children and in early infant diagnosis and
HIV-care programs could not only improve the child health outcomes of these children, but also substantially
lower the global burden of childhood wasting.
This proposal will develop a novel two-way short message service (SMS) platform that targets key barriers to
improving nutritional care for HEU and HIV-infected children. This intervention will combine a maternally
administered malnutrition monitoring system (MAMMS) with infant and young child education (IYCF) delivered
by SMS. After developing the intervention using participatory design methods, we will complete a proof-of-
concept quasi-experimental trial of MAMMS-IYCF in the R21. If the R21 milestones are meet, we will use the
R33 to conduct a randomized trial testing the effectiveness of MAMMS-IYCF at reduced the incidence wasting,
and the duration of wasting treatment. During this trial we will also assess the cost and cost-effectiveness of
MAMMS-IYCF, and to better understand which barriers are being successfully addressed by intervention we will
measure its effect on key attitudinal and behavioral outcomes including trust in the healthcare system, intention
to seek if a child becomes wasted, and IYCF knowledge. This trial will generate the evidence necessary to
integrate MAMMS-IYCF interventions into existing HIV-mHealth programs across the globe, and improve the
outcomes of children in early infant diagnosis and HIV-care services while also substantially lowering the global
burden of childhood wasting.

Public health relevance
PROJECT NARRATIVE Children with HIV-infection and those exposed to HIV without infection are at very high risk of becoming wasted (low weight-for-height or mid upper arm circumference). In the R21 phase of this grant, we propose to develop and test a novel mHealth intervention, called MAMMS-IYCF, that aims to facilitate the prevention and treatment of childhood wasting among these children. During the R33, we will then conduct a randomized clinical trial to establish the effectiveness of this novel intervention at improving child health outcomes.